pan-XLSM: an AI-powered microscopy platform for imaging and analysis of highly expanded tissue samples

Project Summary
Addressing the complexities of biological function and disorders at the molecular level requires
a spatial biology technology that can map the 3D distribution of molecular markers at the
nanoscale within tissues. While spatial proteomics technologies have revolutionized in situ
molecular profiling of tissues, limitations in resolution, epitope accessibility, sample degradation,
and 3D imaging capability hinder their widespread impact. To address these issues, we
developed pan-Expansion Microscopy (pan-ExM), achieving 3D multiplexed protein imaging
at ~20 nm resolution in 3D ultrastructural context. Despite its promising adoption, pan-ExM is
still a manual, labor-extensive, and data-intensive process, underscoring the need for
automation. This is the focus of our project. Termed pan-XLSM, we propose to develop an
automated fluidics light sheet microscope and a robust software platform for AI-driven
image segmentation and analysis. Panluminate, Inc. is a leading company in the Spatial
Biology field. Our proposed project aims to develop pan-XLSM and validate it for the
characterization of mitochondria morphology disruption in kidney, liver, and brain tissues.
Specifically, we propose to (1) develop a commercial prototype of an automated
microfluidics axially-swept light-sheet microscope; (2) develop AI-driven image analysis
software for sub-organelle segmentation; and (3) characterize mitochondria
ultrastructure disruption in kidney, liver, and brain tissues as test bed applications. The
developments proposed in this project will significantly enhance panluminate's existing
commercial preparation service. Pan-XLSM will offer our customers a cutting-edge, automated
3D imaging and segmentation analysis module that surpasses current technologies by far.
Additionally, this project will pave the way for the future commercialization of a standalone
platform product.

Public health relevance
Project Narrative Mapping the complexities of biological functions and disorders at the molecular level requires a technology capable of visualizing the 3D distribution of molecular markers within tissues at the nanoscale. In this project, we will develop pan-XLSM, the first automated three-dimensional spatial biology platform for multiplexed protein imaging at ~20 nm resolution, and validate its use in characterizing mitochondrial morphology disruptions in kidney, liver, and brain tissues. This advancement is crucial for advancing public health, as it aims to revolutionize the analysis of tissue architecture and cellular interactions, opening new possibilities for diagnosis, treatment, and prevention in various fields of medicine.